Implementation of a liquid handler that can increase capacity of SARS-CoV-2 sequencing in animals with COVID-19.

SUMMARY
The overall goal of this project is to purchase equipment that will increase capacity and
speed up the library prep workflow and whole genome sequencing of the SARS-CoV-2
virus in companion animals by implementing an automated library prep process
(NEBNext® ARTIC SARS-CoV-2 Companion Kit with ARTIC primers) and adding higher
computing capabilities. Automating the library prep process with an affordable and versatile
Opentron OT-2 liquid handling robot, in a one-way sequencing workflow, will benefit the
laboratory by increasing throughput; improving sample consistency; minimizing contamination;
freeing up hands-on time; reducing technician strain and fatigue; and minimize tech errors.
Installation of a high-end computer workstation dedicated to sequencing and bioinformatics will
significantly speed up the basecalling process and SARS-CoV-2 strain identification. This
equipment proposal has three specific aims. 1) Purchase and install an Opentron OT-2 liquid
handling robot in the new NDSU-VDL Sequencing Laboratory Section to maintain a one-way
next-generation sequencing (NGS) workflow that will minimize contamination. The NDSU-VDL
is familiar with the operation of OT-2 robots and hands-on library preparation. 2) Write a custom
protocol in Python script for the OT-2 robot to automate the library prep steps for the NEBNext
ARTIC SARS-CoV-2 Companion Kit for Oxford Nanopore Technologies (MinION) sequencers.
The script will be made freely available to OT-2 users through protocol.io and/or github. 3)
Purchase and install a high-end computer workstation to run MinION sequencers, complete
basecalling, and for downstream bioinformatic analyses on SARS-CoV-2 companion animal
samples (i.e. feline and canine respiratory swabs).

Public health relevance
NARRATIVE Equipment from this project will increase the capacity of next-generation sequencing of SARS- CoV-2 in companion animal samples by automating (and scaling up) the next generation sequencing (NGS) library prep process and increasing the speed of basecalling on MinION sequencers. This project will demonstrate the utility of a reasonably priced liquid handling robot (Opentron OT-2) and make the custom protocol script publicly available and customizable for other laboratories. Ultimately, implementation of the OT-2 robot and increased computing power increase the NDSU-VDL’s sequencing capacity for targeted and whole genome sequencing that has implications for not only SARS-CoV-2 but other zoonoses, emerging infectious diseases, novel pathogens, endemic pathogens, and antimicrobial resistance gene detection in animal samples.